Wicked Smart Pad: Washable Sensorized Bedding for the Prevention and Detection of Moisture Events

PROJECT SUMMARY
Due to decreased mobility, deterioration in activities of daily living, and neurological decline that contributes to
loss of bladder control, incontinence is a leading comorbidity for those individuals suffering from Alzheimer’s
disease and related dementias (ADRD). Individuals with incontinence are susceptible to the development of
pressure ulcers (PUs) and other iatrogenic skin injuries that are often regarded as an inevitable part of aging.
Incontinence and related dermatological conditions are a significant comorbidity in senior residents with PUs
occurring in nearly 40% of advanced dementia patients. As such, maintaining skin integrity in ADRD patients is
an ever-present challenge for healthcare providers and caregivers as well as a significant financial burden. Early
detection of moisture events mitigates the complications associated with incontinence, improving the quality-of-
care patients receive. To address this need, Wicked Sheets, a Kentucky-based, woman-owned business, has
developed the Wicked Smart Pad (WSP) -- a washable and reusable, sensorized bedding pad system. It alerts
caregivers when a moisture event occurs via wireless communication, collecting vital information to support the
care team. In Phase I, the PI and the collaborating site, Atria Park of Great Neck, New York, evaluated the
feasibility and usability of our WSP system, its acceptability by care staff and residents alike, and identified key
areas for improvement in their initial design. Our team tested 200 WSPs at three locations involving 36 memory
care residents for 8-12 weeks each. Use of the WSP real-time alerts allowed staff to establish the Incontinence
Response Rate (IRR) as a metric for care delivery; reduced average spillovers to a single event in six weeks;
reduced 35-minute bedding changes to a five-minute exchange of the WSP; and coincided with zero observed
bedsores in participating residents. We also constructed the Wicked Smart dashboard – an interface for memory
care staff enabling them to view moisture event data over several months for any resident – to improve
operational intelligence and curation of data-driven staffing and resident care plans. In this Phase II proposal,
we aim to address challenges identified during our pilot study, namely the need for improved hardware design
and expanded compatibility of the accompanying software, by revising our hardware and software systems for
improved integration with care staff needs and to meet industry and regulatory standards. Subsequently, we aim
to validate our improved designs and assess the efficacy of the WSP system in reducing incontinence events by
informing resident care schedules through a multi-site single-arm clinical study in partnership with Atria Senior
Living. Completion of Phase II will result in a commercially viable WSP platform ready for deployment in memory
care facilities that can reduce the burden of incontinence care, reduce the incidence of PUs and other
incontinence related skin conditions, and improve resident quality of life.

Public health relevance
PROJECT NARRATIVE Patients suffering from Alzheimer’s disease and related dementias (ADRD) are at an elevated risk of developing pressure ulcers (PUs) and skin breakdowns as a result of incontinence; together, incontinence and skin-related comorbidities contribute to lower quality of life for ADRD patients while incurring significant care costs and caregiver distress. To address this need, Wicked Sheets has developed the Wicked Smart Pad: a washable and reusable sensorized system that provides ADRD caregivers with early detection of moisture events. Our Wicked Smart Pad is the first adult incontinence solution that combines active moisture notification and passive moisture management into a durable and reusable cost-effective platform for improving care delivery and increasing ADRD patient quality of life.